Role of PTEN and PI-3 Kinase in Medulloblastomagenesis

Medulloblastoma (MB) is a cancer arising within the cerebellum, and is the most common malignant brain
tumor in children. Current care which relies on radiotherapy and chemotherapy, only cures 60% of patients,
and has serious long-term neurocognitive sequelae in survivors, hence the unmet medical need to develop
more efficacious, less toxic therapies for this disease. Malignant brain tumors including the sonic hedgehog
(SHH) subgroup of MB are driven by tumor propagating cells (cancer stem cells; CSCs) expressing the cell
surface glycoprotein CD15. A knowledge gap exist in that the molecular mechanisms controlling CSC and non
CSC phenotypes are poorly delineated. The central hypothesis for this proposal is that the PI3K/PTEN
signaling axis exerts control over the CSC phenotype in SHH MB and hence represents a target for therapeutic
exploitation with PI3K inhibitors. Importantly, work from our laboratory has demonstrated that PTEN
expression is suppressed in the CSC compartment of the Smo transgenic (SHH pathway) mouse model of MB.
The clinical relevance of the PTEN deficient Smo transgene mouse model is highlighted by our finding that
PTEN expression is lost in human MB, and the observation that PTEN loss correlates with poor survival in MB
patients. Our grant proposal, guided by our preliminary data proposes 3 specific aims: 1) Determine if genetic
alterations in PTEN or specific isoforms of PI3K are necessary and/or sufficient for SHH driven CSC phenotype
and tumorigenesis 2) Utilize high throughput kinome library screens and genomic profiling of mouse and
human MB CSCs and non CSCs to identify a molecular signature and synthetic lethality effects which will
predict sensitivity or resistance to a PI-3K inhibitor. 3) Elucidate the epigenetic mechanism by which PTEN is
regulated in the CSC compartment in human SHH PDX models and the SmoTg GEMM model; Focused on
PTEN specific miRNA regulatory networks. We will use the Math1creER recombinase to generate the
conditional deletion of PTEN, p110 and/or p110 in normal cerebellar granule neuronal precursor cells
(GNPs) or in the CSC compartment and determine the effects on the development of MB and CSC phenotype.
In Aim 2, we will expand upon our recent report demonstrating the activity of the PI3K inhibitor, BKM120
against CSCs to include synthetic lethality screens with other targeted agents and conventional
chemotherapeutics. An innovative component of our application is the recent discovery of a novel miRNA
network which epigenetically regulates PTEN in the CSC compartment which is associated with the CSC
phenotype. This observation will be explored in our GEMMs , MB PDX models and in human MB tumor
samples to determine the role of these miRNAs in the regulation of PTEN, PI3K and the CSC phenotypes
including tumor initiating activity. The proposed work is significant in that it will: 1) establish a role for PTEN,
p110 and p110 in CSC biology in MB 2) identify novel synthetic lethalities in combination with PI3K inhibition
in MB CSCs and 3) elucidate a role for miRNA networks in the control of PTEN and CSC phenotypes.

Public health relevance
Project Narrative The proposed research is relevant to public health because the discovery of signaling pathways that control medulloblastoma tumor growth, survival and progression will ultimately be expected to increase our understanding of the pathogenesis of malignant diseases involving cancer stem cells. Thus the proposed research is relevant to the part of the NIH’s mission that pertains to fundamental knowledge that will help to reduce the burden of human disability as relates to the treatment of adult and childhood cancer.